NNLM Web Services Office (NWSO)

NWSO Core Summary/Abstract
Information Technology (IT) governance provides a structure aligning IT with organizational
strategy. A formal IT framework supports the Network of the National Library of Medicine
(NNLM) in achieving measurable results as well as organizational strategies and
goals. This governance structure integrates the needs of RMLs, NNLM Offices and Centers,
and stakeholder interests. The NNLM Web Services Office (NWSO) ensures IT functions
support NNLM organizational strategies and objectives.
The University of Maryland, Baltimore (UMB) is eager to serve as NWSO, working with RMLs
and NNLM Offices and Centers, and incorporating network member feedback. The UMB NWSO
Team supports innovation, accountability, and principles of Diversity, Equity, and Inclusion (DEI)
in its management of NNLM user-centric systems. Through engagement and collaboration,
the UMB NWSO Team integrates web services, maximizes network member engagement,
supports funded projects’ life cycles, provides education addressing the needs of a diverse
workforce, and applying systems for managing collaborative programs.